Innovations in treatment adherence in pediatric eosinophilic esophagitis

PROJECT SUMMARY
Medication nonadherence leads to increased morbidity, mortality, and costs the US healthcare system
hundreds of billions of dollars annually. While there have been decades of research regarding nonadherence,
newer research shows that interventions that focus on behavior change, and specifically, habit-building, have
the most potential to result in improvement. Given their higher rates of nonadherence and decreased self-
management skills, adolescents with chronic conditions will benefit most from medication adherence
interventions. Our prior work shows that adolescents with eosinophilic esophagitis (EoE) – a chronic immune-
mediated inflammatory disease of the esophagus with a rapidly rising incidence – have low medication
adherence rates secondary to lack of planning and forgetfulness. Thus, we created a prototype of a clinical tool
(a habit-based medication “Action Plan”) and iteratively modified it using stakeholder engagement. The specific
aims of this proposal are to: 1) establish an optimal version of this tool - the “Medication Habit Action Plan
(MHAP)” – through usability testing (end-user testing with patients and nurses), 2) conduct a pilot randomized
controlled trial of the MHAP to determine feasibility and inform a larger multicenter future hybrid effectiveness-
implementation trial, and 3) measure the effect of dupilumab on adherence and EoE clinical outcomes in
nonadherent adolescents using a prospective cohort study design. This career development award is designed
to support the transition of Pooja Mehta, MD, MSCS, an Assistant Professor of Pediatrics at the University of
Colorado, into an independent clinician-scientist and to achieve her long-term career goal of improving
outcomes in children with chronic gastrointestinal diseases. Guidance from a multidisciplinary mentorship team
(Dr. Glenn T. Furuta- renowned EoE clinical researcher, Dr. Bethany Kwan- dissemination and implementation
scientist, and Dr. Sheana Bull- user-centered design and technology expert) will be coupled with training in 1)
clinical trial design and conduct, 2) dissemination and implementation science, and 3) healthcare data
integration across multiple institutions. Together, these will provide Dr. Mehta with the foundation needed to
successfully create and test adherence-related interventions in large-scale multi-center pragmatic trials. The
University of Colorado provides a unique environment to conduct pragmatic research and is supported by
collaborative partnerships between The Adult and Child Consortium for Health Outcomes Research and
Delivery Science, The University of Colorado Mobile Health Impact Laboratory, Children's Hospital Colorado
Gastrointestinal Eosinophilic Diseases Program, and Denver Health (Denver's safety net hospital). EoE serves
as an ideal disease model to study habit-based medication adherence interventions and will have widespread
applicability to a broad range of chronic pediatric gastrointestinal diseases. Ultimately, completion of this
research proposal and career development plan will help Dr. Mehta achieve her overall career goal of
addressing treatment nonadherence in children with chronic diseases to improve child health outcomes.

Public health relevance
PROJECT NARRATIVE Inadequate medication adherence is common in adolescents with eosinophilic esophagitis - a chronic inflammatory condition of the esophagus - and leads to poor health outcomes and increased healthcare spending. This proposal seeks to conduct pilot testing of a new medication adherence intervention for adolescents with eosinophilic esophagitis and measure the impact of dupilumab (a newly approved biologic therapy for eosinophilic esophagitis) on nonadherent adolescents. Results of this proposal have widespread applicability to all adolescents with chronic diseases for whom medication nonadherence remains an important public health concern.